Mu Opioid Receptor Modulator Development to Treat Opioid Use Disorder

Project Summary
The United States is currently in an opioid crisis, and NIDA is committed to research on the mechanisms and
treatment of opioid use disorder. Current Food and Drug Administration-approved pharmacotherapies for
opioid use disorder include the MOR agonist methadone, the MOR partial agonist buprenorphine, and the
MOR antagonist naltrexone. However, the clinical utility of all three compounds is limited for various reasons.
Therefore, it is imperative to develop novel and effective drug candidates with enhanced therapeutic effects
and reduced undesirable effects. Recently, we have identified several highly selective and potent MOR
modulators as novel leads for opioid use disorder treatment. They all showed more promising pharmacological
profiles compared to other known drugs in this category. The current proposal will focus on further
development of these leads for preclinical IND-enabling studies, and dynamic drug discovery and development
pipeline construct. Four integrated specific aims will be pursued in this project in two phases. In the UG3
phase, we will 1) further Validate therapeutic profiles of the current leads with self-administration and PK
studies, and 2) expand the small molecule library to build a dynamic drug discovery and development pipeline.
In the UH3 phase, we will 1) conduct preclinical IND-enabling studies on the lead(s) identified from UG3 phase,
and 2) compare in vivo pharmacokinetics and pharmacodynamics profiles of the new hits from UG3 phase with
current leads to define our next generation of lead compound(s).

Public health relevance
Relevance Opioid use disorder has become a real threat to our society. This proposal will focus on the development of highly selective mu opioid receptor modulators as novel opioid use disorder treatment by applying multidisciplinary tools, including drug discovery and development, medicinal chemistry, neuropharmacology, and behavioral pharmacology. The goal of this project is to identify clinical candidates as suitable treatments for opioid use disorder.